An enabling approach for deep metaproteomic characterization ofmicrobial contributors to tumorigenesis in clinical samples

SUMMARY
Microbes, specifically bacteria, are known to influence the host tumor microenvironment during cancer
development. Bacterial proteins perform biochemical functions directly, and indirectly, interacting with host
cancer cells, regulating the expression of genes and pathways associated with tumorigenesis. Mass
spectrometry (MS)-based metaproteomics offers a powerful means to characterize functional proteins that
contribute to microbe-host interactions in cancer. However, metaproteomic analysis is limited by the low
abundance of microbes compared to host cells within the tumor microenvironment. Current approaches for
enrichment (e.g., differential centrifugation) only modestly increase detection of microbes, while culturing
samples to boost bacterial abundance suffers from loss of unculturable microbes and their in vivo. An approach
to efficiently enrich microbes directly from clinical cancer samples, such as tissue biopsies and fluids, and enable
deep metaproteomic analysis, would transform our ability to investigate the mechanisms by which non-host
microorganisms influence carcinogenesis and treatment. To address this challenge, we propose to develop and
optimize a novel approach for enriching microbes from clinical cancer sample (CS) specimens, by developing a
novel approach based on bio-orthogonal non-canonical amino acid tagging (BONCAT), coupled with cell sorting
enrichment and sensitive MS-based metaproteomics. Our interdisciplinary team, which includes clinical and
translational cancer research partners, brings the necessary expertise and access to clinical samples necessary
for developing, optimizing, and demonstrating effectiveness of our approach. Our work will pursue these Aims:
Specific Aim 1. Optimize and evaluate CS-BONCAT in samples of known composition; Specific Aim 2.
Optimize and demonstrate proof-of-concept using CS-BONCAT to enable metaproteomic analysis of clinical
cancer samples. We will focus on optimization in brush biopsy samples from oral cancer patients, and further
demonstrate effectiveness in evaluating bacterial metaproteomes associated with colorectal and ovarian cancers
from clinical samples. We will evaluate the effectiveness of our optimized approach through quantitative
performance measures, ensuring CS-BONCAT will be useful for the cancer research community. We will
promote adoption of CS-BONCAT by cancer researchers as part of a complete, clinical metaproteomics workflow
through accessible online and on-demand multimedia resources. Once completed, we will deliver a
transformative approach to better understand microorganism contributors to tumorigenesis, impacting diagnosis,
prevention, and treatment for many cancer types.

Public health relevance
PROJECT NARRATIVE It is known that microorganisms (e.g., bacteria) directly interact with human host cells and influence cancer development, but we lack understanding of the molecular mechanisms through which these interactions happen. We will develop a new approach, termed CS-BONCAT (cancer sample bio-orthogonal non-canonical amino acid tagging) to more completely characterize the proteins expressed by bacteria found in cancer samples collected in the clinic, providing a transformative method for understanding host-microorganism interactions in cancer.